TWO PHOTON ACTIVATION AND IMAGING OF CHR2 EXPRESSING EXCITABLE CELLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Two-photon excitation with a near-IR laser micro-beam is used to investigate activation of channelrhodopsin 2 (ChR2) in excitable cells for the first time. By measuring the fluorescence intensity of the calcium indicator dye calcium orange at different wavelengths as a function of power of the two-photon excitation microbeam, we determined the activation potential of the near IR microbeam as a function of wavelength. The two-photon activation spectrum is found to match measurements carried out with single-photon activation. However, two-photon activation is found to increase in a non-linear manner with the power density of the two-photon laser microbeam. This approach allowed us to activate different regions of ChR2-sensitized excitable cells with high spatial resolution. Further, in-depth activation of ChR2 in a spheroid cellular model as well as mouse brain slices was demonstrated by use of the two-photon near-IR microbeam which was not possible using single-photon activation. This all-optical method of identification, activation, and detection of ChR2-induced cellular activation in genetically targeted cells with high spatial and temporal resolution will provide a new method of performing minimally invasive in-depth activation of specific target areas of tissues or organisms that have been rendered photosensitive by genetic targeting of ChR2 or similar photo-excitable molecules.